2014 AUA Basic Sciences Symposium, "New Perspectives in Pelvic Health"

DESCRIPTION (provided by applicant): R13 Conference Support Application AUA Basic Sciences Symposium: New Perspectives in Pelvic Health Summary: This application requests support for the American Urological Association (AUA) Basic Sciences Symposium: New Perspectives in Pelvic Health. The 2014 AUA Basic Sciences Symposium, New Perspectives in Pelvic Health, will be held at the 2014 AUA Annual Meeting in Orlando, Florida on Friday, May 16, 2014 from 1:00 to 5:00 p.m. The support would provide travel awards for approximately 20 young investigators to attend the meeting scheduled for May 16, 2014 at the Orange County Convention Center in Orlando, Florida. The purpose of this meeting is to provide an overview of our current understanding of pelvic health and to gain insights on improving patient care. The aim is to provide a broad perspective of the potential and limitations of the field with a view to developing interest in more basic and translational research in this area. We will recruit participation of new investigators, especially minorities and women, to this outstanding program. The primary investigator for the meeting, Leo Giambarresi, PhD, is the Director of Research at the American Urological Association. The Program Co-Chairs are: Lori Birder, PhD, Professor of Medicine and Pharmacology, University of Pittsburgh School of Medicine and Toby Chai, MD, Vice Chair for Research, and Director of the Female Pelvic Medicine Reconstruction Surgery Program, Yale University School of Medicine. Tamara Bavendam MD, the Senior Scientific Officer and Program Director of Women's Urologic Health within the Division of Kidney, Urologic and Hematologic Diseases at NIDDK is serving as a consultant to the planning committee for this conference.

Public health relevance
PUBLIC HEALTH RELEVANCE: In 2014, the American Urological Association (AUA) in collaboration with the NIDDK will offer a Basic Sciences Symposium, entitled "New Perspectives in Pelvic Health." This joint effort between the AUA and the NIDDK is intended to be a rigorous and in-depth discussion of an overarching topic area that will spur progress in benign urologic conditions and that will attract leaders in the field, influential urology researchers, clinical urologists and early career investigators to the AUA Annual Meeting. The information presented at this meeting by experts in their respective fields, and the interactions and collaborations resulting from this meeting, are expected to promote a better understanding of the processes related to pelvic health and how they contribute to the development of lower urinary tract symptoms, and are expected to stimulate translation of laboratory findings into clinical settings and vice versa. The meeting is organized into three scientific sessions with ample question and answer periods. To add breadth and to emphasize the need for urgent progress in this area, the meeting will also feature a "Public Perspective" session to be provided by Missy Lavender, the Executive Director of the Women's Health Foundation. Leaders of the NIH Office of Research on Women's Health and the AUA and its affiliated specialty societies, including the Society for Basic Urology Research (SBUR), the Society for Urodynamics, Female Pelvic Medicine, and Urogenital Reconstruction (SUFU), the Sexual Medicine Society (SMS) and the Society for the Study of Male Reproduction (SSMR) will be specifically invited to attend. Also in attendance will be Program Officers from the NIDDK and the National Institute of Aging.